Next generation brain-machine interfaces controlled synergistically with artificial intelligence

PROJECT SUMMARY Over 5 million people in the USA — nearly 1 person in 50 — live with a form of paralysis due to causes including stroke, spinal cord injury, multiple sclerosis, and ALS. People who have lost the ability to move also lose a profound sense of control, freedom, and independence in their lives. But paralysis does not take away one's intent or desire to move; the brain still encodes these thoughts through neural signals. Brain-machine interfaces (BMIs) aim to restore the ability to communicate with the world by translating these neural signals into actions. BMIs decode neural signals into the movements of a computer cursor on a screen or a robotic arm, allowing the user to interact with the world autonomously. While BMIs have existed for over two decades, they have remained in pilot clinical trials dating back to 2004 and have not achieved widespread use. The key reason for this is that BMI performance has not achieved levels of performance that overcome their costs and risks. This is true for both invasive BMIs requiring neurosurgery, as well as for non-invasive BMIs, which can be used without surgical procedures but achieve low performance. This proposal aims to dramatically increase the quality of life for millions with paralysis by making widely accessi- ble BMIs available within the next ﬁve years. To achieve this groundbreaking goal, there needs to be a paradigm shift in the way BMIs fundamentally operate. Revolutionary next generation BMIs making signiﬁcant impact must be designed to: (1) achieve categorically unprecedented performance not possible with current BMI systems (e.g., over an order of magnitude improvement) and (2) minimize cost to patients, ideally being non-invasive. En- tirely novel BMI architectures are needed to fundamentally transcend a performance vs cost trade-off, achieving excellent performance at lower risks and costs. To meet this need, I propose to develop a next-generation BMI where the user and an artiﬁcial intelligence (AI) agent synergistically cooperate. We term this an “AI-BMI.” The AI agent predicts the user's intended motor actions and synergistically helps to complete them. Critically, the AI agent aids the precise and detailed execution of the user's intended movements, augmenting performance. By doing so, this architecture fundamentally changes the design objectives of BMIs from neural decoding of precise movements (difﬁcult) to behavioral and neural inference of the user's intent (easier). Non-invasive AI-BMIs, if successful, would be transformative, enabling next generation BMI technology that allows people with paralysis to once again move, but mitigates medical risks associated with neurosurgery and lowers system costs.

Public health relevance
PROJECT NARRATIVE For people who have lost the ability to move due to movement disorders, including paralysis and ALS, brain- mahince interfaces (BMIs) aim to restore movement and communication by decoding neural activity from motor regions of the brain to control prosthetic devices. The proposed work aims to create and optimize a new class of transformative BMIs that incorporate an external artiﬁcial intelligence agent who infers the user's intent and helps to carry out prosthesis actions. If successful, these new BMIs would signiﬁcantly increase BMI performance while lowering risks and costs, enabling widespread use.